PROSPECTIVE STUDY OF ANGIOGRAPHIC INTRAHEPATIC PORTO-CAVAL STENT PLACEMENT

To study the role of angiographic intrahepatic stint placement or the acute and long term treatment of bleeding gastrointestinal varices secondary to chronic liver disease.